Regulation of postsynaptic protein interaction networks in complex brain disorders

Project summary:
The signaling specification of the post synaptic membrane known as the post-synaptic density (PSD), is one of
the most complex signaling machineries in the neuron. Many of the genes that have been implicated as risk
factors for the psychiatric disorders are thought to affect PSD proteins. Yet with these genetic discoveries,
there has been a gap in defining underlying biological mechanisms that contribute to dysfunction at the PSD in
complex brain disorders. Our primary objectives are to determine how mutations associated to schizophrenia
(SCZ), disrupts protein interaction networks (PINs) at the PSD, how risk factors are functionally organized in
PINs and how they are regulated by synaptic activity.
We will use mouse genetic models, including the protein kinase TNiK and a mutant -model of SHANK3 found
in patients with SCZ, mass spectrometry analysis, biochemical assays, and computational approaches to
explore not only the normal function of PSD PIN in responding to synaptic activity, but also translate the human
genetic findings into knowledge of how the function of this network is affected by mutations associated with
psychiatric disease.

Public health relevance
Narrative Psychiatric disorders such as schizophrenia, are highly prevalent, start early in life, damage the affected individuals’ productivity, and cause a high burden to individuals, families and society. Despite the profoundly negative effects of these disorders on public health and society, progress in the discovery of new therapeutic targets and mechanisms has been slow. The proposed research will increase our understanding of the molecular changes occurring at the synapse, that are likely to be important in the development of schizophrenia, helping the possibility to bridge the gap between the discoveries of human genetics and essential synaptic pathways.